Plasticity of Functional Networks in Auditory Cortex

PROJECT SUMMARY
In the developing nervous system, millions of neurons coordinate and refine their connections to give
rise to incredibly complex behavior, such as speech and language. These particular behaviors require the
proper function of intricate networks within the auditory cortex. In this proposal, functional neural networks will
be investigated using high-speed, volumetric imaging within cortical columns during tone-detection behavior in
mice. In addition to characterizing these networks using state-of-the-art network analysis, whether or not these
networks are sufficient to drive behavior will be tested by activating or silencing connected neurons with 3D
holographic stimulation. Understanding how these networks function in normal adults will provide unique
insight into how the auditory cortex functions as a decision-making unit and provide a basis for understanding
what happens when these networks are disrupted.
Another major goal of this proposal is to investigate network reorganization during the critical period, a
remarkable period of plasticity during cortical development in which ocular dominance columns from in the
visual cortex and tonotopic maps sharpen in the auditory system. Previous studies have observed that rearing
animals in the presence of an intermittent tone during this period dramatically increases the cortical space
devoted to that tone. Despite the enhanced response to that tone, animals had difficulty discriminating minor
differences in tones played around the reared tone. Paradoxically, preliminary results from our lab indicate that
tone rearing dramatically decreases the cortical space that responds to that tone. This proposal seeks to
reconcile these differences with similar approaches as those described above, which allows for simultaneous
imaging of hundreds to thousands of neurons within a volume, but in mice reared with intermittent tones during
the critical period. Network analysis will uncover the extent of the reorganization and provide key insights into
how cortical circuits responds to early environmental sounds.
Lastly, this proposal seeks to investigate which cell types orchestrate circuit reorganization during the
critical period. In the developing cortex, a developmentally transient group of cells located beneath the cortical
plate seem poised to fulfill this function. These subplate neurons are interwoven into cortical circuits with local
subplate-to-subplate, thalamocortical, and layer IV projections. Quite remarkably, these are the first neurons to
respond to sound in the cortex (even before layer IV). To test if subplate neurons mediate cortical
reorganization, chemo- and optogenetic approaches will be used to silence and activate these cells during the
critical period. Subsequent analysis of functional networks will be performed using volumetric imaging.
Understanding the mechanisms that reorganize these circuits may provide insight into developmental causes
of dysfunctional wiring that arise during this period and offer clues about how to restore plasticity in adult
auditory circuits, which may improve outcomes of cochlear implantation in older, congenitally deaf patients.

Public health relevance
PROJECT NARRATIVE Neural circuits in the auditory system undergo vast changes after hearing onset, forming intricate networks responsible for complex behaviors. This proposal seeks to characterize and determine how these networks form using new optical and genetic technologies that enable rapid assessment of hundreds to thousands of brain cells and the ability to directly manipulate those cells in awake, behaving animals. Understanding how these networks form may provide clues about auditory disorders that are thought to arise from miswiring of auditory cortical circuits, including autism spectrum disorder, auditory processing disorder, schizophrenia, and cerebral palsy.